Targeted Analysis Resource

PROJECT SUMMARY/ABSTRACT: TARGETED ANALYSIS RESOURCE
The Minnesota HHEAR Targeted Analysis Resource will combine the vast analytical chemistry expertise of
investigators at the University of Minnesota and the Public Health Laboratory, Minnesota Department of
Health. This Targeted Analysis Resource will serve the research community by providing state-of-the art
quantitative analyses of biomarkers directly indicative of environmental chemical exposures including parent
compounds, metabolites, and DNA or protein adducts. This Targeted Analysis Resource builds on the
established methods and expertise that have been applied successfully in the Minnesota Targeted Analysis
Resource of the CHEAR program. The Targeted Analysis Resource will provide timely and reliable quantitative
data in three major areas of environmental and lifestyle exposures highly relevant to human health:
1. Exposure to tobacco-specific compounds;
2. Exposure to environmental, lifestyle, and nutritional toxicants and cacinogens;
3. Variations in levels of endogenous and dietary compounds.
The tobacco-specific compounds are critical for establishing exposure to tobacco products or e-cigarettes.
They include the full suite of urinary nicotine metabolites (nicotine, cotinine, 3′-hydroxycotinine and their
glucuronides, and nicotine-N-oxide); cotinine and 3′-hydroxycotinine in serum, dried blood spots, and toenails;
and the tobacco-specific carcinogen metabolites 4-(methylnitrosamino)-1-(3-pyridyl)-1-butanol (NNAL) and its
glucuronides in urine, blood, and toenails. The environmental, lifestyle, and nutritional toxicants and
carcinogens and metabolites include mercapturic acid (MA) metabolites of volatile toxicants such as
acrylonitrile (CEMA), benzene (SPMA), acrolein (3-HPMA), crotonaldehyde (HMPMA), and ethylene oxide
(HEMA); urinary metabolites of furan; urinary metabolites of polycyclic aromatic hydrocarbons (PAH) such as
1-hydroxypyrene (1-HOP) and phenanthrene tetraol (PheT); urinary metals; per- and polyfluoroalkyl
substances; opioids, cannabinoids, and designer drugs; leukocyte DNA adducts of formaldehyde,
acetaldehyde, and acrolein; and DNA adducts of heterocyclic aromatic amines in formalin fixed paraffin
embedded tissues. The endogenous and dietary compounds include the carcinogenic urinary heterocyclic
aromatic amines 2-amino-3,8-dimethylimidazo[4,5-f]quinoxaline (MeIQx) and 2-amino-1-methyl-6-
pheynylimidazo[4,5-b]pyridine (PhIP) and their metabolites; PhIP in hair; tissue 8-hydroxydeoxyguanosine;
plasma carotenes, lycopenes, tocopherols, ascorbic acid, vitamin D derivatives, isoprostanes, and urinary
polyphenols.